Addressing Depression for African American Adults with Hypertension: Applying Community-Engaged Implementation Science

PROJECT SUMMARY/ABSTRACT
At least 1 in 4 adults with hypertension also has depression. The rate of depression is even higher among
African American adults compared to white adults with hypertension. Depression is associated with worse blood
pressure control, poorer adherence to antihypertensive medications, and ultimately poorer cardiovascular
disease outcomes. Thus, treating depression has great potential to improve hypertension outcomes and address
cardiovascular disease disparities among African Americans. An important limitation of available evidence-based
interventions is that they are not adapted for the context in which they are implemented, thereby reducing their
effectiveness and reach.
This project proposes to: 1) use health informatics to characterize the contextual factors that influence
depression, hypertension, and their association among African Americans on the South Side of Chicago, a
community with significant cardiovascular disease disparities; 2) collaborate with community partners to select
an evidence-based, culturally appropriate intervention for depression and adapt it for the implementation context;
and 3) pilot the adapted intervention among African American adults with depression and hypertension on the
South Side of Chicago. By collaborating closely with community partners to adapt the intervention for the context,
the resulting implementation protocol holds great potential to extend the reach of and engagement in the
intervention. The implementation and effectiveness results will increase specificity and competitiveness of a
subsequent grant proposal to conduct a full-scale trial.
Dr. Allison Carroll’s overarching career goal is to implement evidence-based behavioral interventions to
address cardiovascular disease disparities. Through the proposed research project, training plan, and
mentorship, Dr. Carroll will expand her knowledge and skills related to implementation science methodology,
particularly focused on blood pressure control; behavioral interventions to address health disparities; community-
engaged research; and health informatics. Dr. Carroll’s proposed research aims and training goals are well-
aligned with the priorities of the National Heart, Lung, and Blood Institute as well as the Department of Psychiatry
and Behavioral Sciences at Northwestern University Feinberg School of Medicine. The K23 Mentored Patient-
Oriented Research Career Development Award will provide Dr. Carroll with the necessary tools to become a
successful independent investigator.

Public health relevance
PROJECT NARRATIVE Depression is an independent risk factor for hypertension, and promising evidence suggests that treating depression can improve blood pressure control. This study will develop a community-informed intervention and implementation approach to treat depression among African American adults with comorbid depression and hypertension living on the South Side of Chicago. Results will inform public health efforts to widely disseminate depression interventions to promote blood pressure control among populations with significant cardiovascular disease disparities.